DEVELOPMENT OF RADIATION SYNOVECTOMY IN RHEUMATOID ARTHRITIS

The overall objective of this proposal is to improve the clinical utility of radiation synovectomy in the treatment of rheumatoid synovitis and develop appropriate means to assess the effect of treatment.